Radiopaque 3D printed tissue engineered scaffolds for nerve generation

ABSTRACT
Tissue engineered scaffolds (TES) are employed in regenerative medicine to induce tissue repair in a variety of
organs. Over the last decade we have demonstrated that multichannel, polymer-based TES implanted in nerve
injury sites facilitate functional recovery in rodent models. To augment the clinical utility of TES for peripheral
nerve injury (PNI), we imparted radiopacity to these implantable devices, by doping the polymer devices with
radiopaque tantalum oxide (TaOx) nanoparticles (NPs). With this process, biomedical devices could be
monitored post-implantation by x-ray computed tomography (CT), a workhorse of clinical imaging due to its high
resolution and accessibility. Indeed, implanted radiopaque TES are easily detectable in vivo by CT, enabling
physicians to determine correct TES implantation site, and any displacement, damage and/or degradation. For
PNI, this could reduce the delays to revision treatment that impair functional recovery for patients. Previously the
upper bounds for tolerable TaOx concentration were determined in terms of biocompatibility, cellular growth, and
device mechanics, and lower bounds by CT detection. The long-term goal is now to move the technology towards
the clinic by 1) scaling production of a radiopaque TES using additive manufacturing, 2) confirming
biocompatibility and NP tissue clearance following device degradation, and 3) validating CT as a method for
longitudinal monitoring of nerve devices in a large animal model. To accomplish these goals, ultra-high resolution
3D printing of photoresin/NP composites will be used to create multichannel, radiopaque PNI devices. With
homogeneous and well characterized radiopaque materials, the clearance of NPs will be evaluated in vivo, in a
mouse model, to determine the effect of NP surface chemistry on biodistribution as implants degrade. A major
hurdle in the translation of implants to the clinic is related to implant scale up, as changes in physical dimension
of implants impact tissue repair, making large animal models key for justifying clinical use. Therefore, radiopaque
PNI devices will be monitored in a swine model of sciatic nerve injury, quantifying device features via in situ
imaging and relating imaged features to nerve regeneration and functional recovery over 8 months. Further, the
benefits of an emerging clinical CT paradigm, photon counting spectral CT (PCCT), will be defined as it has the
potential to enable more sensitive imaging, reducing TaOx content, while obtaining higher resolution images at
lower X-ray doses. By demonstrating applicability of radiological monitoring to PNI devices on a human clinical
scale, with no adverse events associated with the radiopaque nanoparticles, success of this project sets the
stage for clinical translation, building on proven biocompatibility of TaOx NPs, customization of 3D printing, and
demonstration of clinical utility in large animal models and with PCCT.

Public health relevance
PROJECT NARRATIVE Peripheral nerve injury represents a major healthcare burden worldwide, that often requires treatment with implanted biomedical devices. By incorporating radiopaque tantalum oxide nanoparticles into devices, clinicians will gain the ability to monitor healing, reducing delays to treatment that jeopardize patient outcomes.